Limited Competition for the Continuation of the Chronic Renal Insufficiency Cohort (CRIC) Hopkins Clinical Center

PROJECT SUMMARY
This application is submitted in response to RFA-DK-22-502, “Limited Competition for the
Continuation of the Chronic Renal Insufficiency Cohort (CRIC) Clinical Centers (U01),” aka Phase 5
of CRIC, for the Hopkins/University of Maryland (Hopkins/UMB) Clinical Center. Since its inception,
CRIC has recruited and followed a racially and ethnically diverse cohort of 5,625 participants with
reduced kidney function at 7 Clinical Centers across the US. As the landmark cohort study of CKD, it
has accomplished extensive biological, physiological, and social phenotyping, longitudinal follow-up,
and ascertainment of clinical and patient-centered outcomes across multiple domains. In the
process, it has made major scientific contributions. In Phase 5, CRIC will have the following aims:
1) ascertain clinical outcomes for all participants including those enrolled in the Phase 4 sub-
protocols,
2) perform analyses linking the sub-protocol measurements to clinical outcomes,
3) integrate data from multiple domains to identify sub-phenotypes underlying the heterogeneity
in CKD progression outcomes,
4) conduct final study visits for the full CRIC cohort eligible for Phase 5,
5) create mechanisms for future data collection via linkages with external sources of health data,
6) generate tools and resources to facilitate ongoing use of CRIC data and biospecimens by a
broad group of investigators after the CRIC Study has officially ended.
Leveraging its vast expertise in the design, conduct, and dissemination of high quality observational
research, the investigative team at Hopkins/UMB contributed substantively to scientific and
operational aspects of CRIC, and ultimately its success. During Phases 1-4 of CRIC, the
Hopkins/UMB Clinical Center was a high performing center that exceeded its recruitment goals during
the Phase 1 and 3 recruitment drives; achieved high re-enrollment and follow-up rates in Phases 2-4;
collected high quality data; implemented the Phase 4 subprotocols; and contributed substantially to
the productivity of the study. Likewise, center investigators and senior staff have consistently had
prominent leadership roles (e.g. Co-Chairs of Recruitment/Retention, Ancillary Studies, and
Publications Subcommittees). In Phase 5, the Hopkins/UMB team is extremely well-positioned to
implement the Phase 5 protocol and contribute substantively as CRIC transitions from an active
cohort study to a long-lasting resource that supports ongoing and future mechanistic, epidemiologic,
and translational investigations.

Public health relevance
Chronic Kidney Disease is an extremely common medical problem. The consequences of chronic kidney disease include kidney failure requiring dialysis or a kidney transplant; cardiovascular disease and stroke; physical and cognitive disabilities; and premature death. The Chronic Renal Insufficiency Cohort (CRIC) Study is a long-term, observational study designed to evaluate factors that might be responsible for these adverse outcomes in adults with chronic kidney disease.